Investigating Helios as a regulator of natural killer cell effector maturation

Project Summary
NK cells play essential roles in the immune response to intracellular pathogens, including
viruses and bacteria, and form an important defense against malignant transformation and
metastasis. In this R21 application, we propose experiments to test the hypotheses that the
transcription factor Helios is a central regulator of undifferentiated NK cells, supporting their self-
rewak and limiting effector maturation. We present evidence that Helios is expressed in the
most undifferentiated of mature NK cells and up-regulated in Ets1-deficient NK cells, which fail
to mature appropriately and have multiple defects in NK cell receptor expression and function.
We will create mice lacking Helios, or Ets1 and Helios, in NK cells to determine whether these
cells show premature effector maturation and altered response to cytokines, tumor cells
(melanoma) or virus (mouse cytomegalovirus). Our studies will provide a foundation for
understand the mechanisms underlying NK cell self-renewal effector maturation.

Public health relevance
Relevance: IFN-γ-producing lymphoid cells play an important role in anti-virus, anti-bacteria and anti-cancer immune responses and therefore it is imperative that we understand the mechanisms that control their expansion and effector function. This project is focused evaluating the role of the transcription factor Helios in NK cell effector maturation and function. The results of these experiments will impact our understanding of NK cell biology and may impact our ability to manipulate the expansion and differentiation of these cells.